ND INBRE Health & the Environment

Abstract A major contributor to health inequities is the lack of a diverse biomedical research workforce that is technically proficient in data management, computer programming, and analytics as well as the ability to work effectively on interdisciplinary teams. This skillset in data science is essential for advancing knowledge of factors that drive disparities using a wide array of data sources and for leveraging information that leads to improved clinical decision-making and the public health of tribal communities. Pipeline programs that introduce students to computational approaches, role models, access to resources, and career opportunities in data science are needed to address the underrepresentation of AI/AN in the biomedical research workforce. Tribal colleges and universities (TCUs) historically have played a pivotal role in preparing students for STEM-related fields that address local workforce needs. (NAS Town Hall, 2021) However, none of the 5 TCUs in North Dakota offer courses or specialized trainng in biomedical or health data science despite the need for this expertise in tribal health organizations. (NIHB, 2019). The Virtual IDeA for Data Science Education (IDSE) hosted by the UNDSMHS will begin to address this gap in data science education by providing a 10-week training in the foundations of data science and analytics adapted from the NIH-supported 8-week VADSTI program.

Public health relevance
Narrative Data science is essential for advancing knowledge of factors that drive disparities using a wide array of data sources and for leveraging information that leads to improved clinical decision- making and the public health of tribal communities.